Deciphering the Molecular Orchestrators of Heterochromatin-Lamina Interactions at the Nuclear Periphery

Deciphering the Molecular Orchestrators of Heterochromatin-Lamina Interactions at the Nuclear
Periphery. Ashley M Karnay
Abstract
It is well established that the eukaryotic genome is segregated within three dimensional nuclear space, with
specific genomic regions adopting subnuclear positions relative to specific nuclear landmarks. One such nuclear
landmark associated is the nuclear lamina (NL) at the nuclear periphery. Positioning of specific genes at the NL
correlates with enrichment in heterochromatin-associated epigenetic signatures, such as dimethylation of Lysine
9 on Histone H3 (H3K9me2), and repression of gene transcription. The dynamic coupling of peripheral
positioning and gene silencing plays a key role in directing crucial developmental processes such as
cardiomyocyte lineage restriction and goes awry in genetic forms of cardiomyopathy and other diseases.
Genomic regions that make contact with the NL are defined as lamina-associated domains (LADs). Distributed
across all chromosomes, these large domains dynamically interact with the NL to release or attach genes and
regulatory elements in accordance with cell-type and differentiation state-specific gene expression programs.
Specifically, loss of LADs results in precocious cardiac differentiation. How chromatin-lamina interactions are
established and maintained remains poorly understood. Endogenously-encoded sequences sufficient for
peripheral targeting of LADs have not been identified, strongly supporting the existence of regulatory proteins,
epigenetic modifications or biomolecular processes capable of mediating chromatin-NL contacts. However, the
precise orchestrators of spatial and temporal dynamics between LADs and the nuclear periphery remain elusive.
By combining targeted manipulations of local transcriptional states and epigenetic signatures with single-cell
microscopy and population-based genomics analysis I will test the hypothesis that the heterochromatin-
associated epigenetic mark H3K9me2 is required to maintain sequestered genomic loci at the nuclear
periphery while transcriptional repression serves to establish chromatin-lamina interactions. These
studies will provide mechanistic insights into how chromatin states and gene activity are coupled to gene radial
positioning. By probing peripheral chromatin organizational principles at the single-cell level while simultaneously
analyzing higher-order genome organization at the population level, I can uniquely dissect the underlying
mechanism mediating the spatial organization of the genome. Elucidating the link between nuclear organization,
human development and disease etiology is crucial to understanding how these relationships impact
organogenesis and disease.

Public health relevance
PROJECT NARRATIVE It is widely known that the eukaryotic genome is segregated within three-dimensional nuclear space, with large, heterochromatic domains sequestered proximal to the nuclear lamina. Elucidating the molecular mechanisms responsible for the organization of the genome at the nuclear periphery will delineate how cell-type and differentiation-state specific chromatin configurations and higher-order genome organization are directed in health and disease. The results of my studies will identify the mechanistic drivers of lamina-associated domain establishment and maintenance, providing a fundamental principle governing peripheral heterochromatin organization that links gene expression, local genomic context and radial positioning.